Investigating the Role of Epiregulin During Human Intestinal Development

PROJECT ABSTRACT
Intestinal Stem Cells (ISCs) are responsible for maintenance and regeneration of the intestinal epithelium, and
reside in a domain called the crypt, supported by physical and biochemical cues that make up the stem cell
niche. Despite the vital role ISCs play in human intestinal development, homeostasis and disease, the
signaling cues that make up the human ISC niche are poorly understood. By analyzing single cell RNA
sequencing data from human duodenal samples spanning approximately 7-to-21-week post conception, we
determined that Epidermal Growth Factor (EGF), which is commonly used to create an artificial in vitro niche
for growing intestinal organoids, was expressed on the differentiated cells of the villus, far from the stem cell
domain. We also identified another EGF family member, Epiregulin (EREG), which was highly enriched in the
stem cell domain and spatial location confirmed to the crypt. Functional experiments suggest that culturing
isolated intestinal epithelium (known as enteroids) in EREG or EGF lead to dramatically different cellular
outcomes and spatial organization. Based on this data, the overarching goal of this proposal is to determine
the functional role of EREG as a novel intestinal stem cell niche cue. We will test the hypothesis that EREG,
and not EGF, is a critical physiologically relevant growth factor for intestinal stem cell homeostasis and plays a
key role in human intestinal development. We will test this hypothesis through the following specific aims: 1)
Elucidate the mechanism by which EGF and EREG act on human ISCs; 2) Assess the role of EREG in a
complex model of the developing human intestine in vitro and following xenotransplantation.

Public health relevance
PROJECT NARRATIVE Recent single cell genomic studies of the human intestine have revealed new biological observations about human development, homeostasis and disease; opening the door to uncover novel insights about fundamental human biology. Using single cell genomic approaches, we have identified a new growth factor, Epiregulin (EREG), which is expressed in the stem cells of the developing human intestine, but which is absent from the murine intestine, suggesting a unique role in human development. These studies will shed light onto normal human intestinal homeostasis and may lead to insights into how perturbations to this homeostasis leads to disease.